Identification of viral exposure signatures for early detection of liver cancer

Viruses are known to affect human health by altering host immunity and leaving a unique molecular footprint during infection, which makes the interplay between the human virome and the host a crucial molecular window reflecting the pathogenesis of human chronic diseases including cancer. The CCR Pan-Microbial Serology Facility has successfully developed and implemented a standard operating protocols, including a pipeline from data acquisition to data analysis, for an emerging phage-immunoprecipitation technology. This technology allows comprehensive profiling of individuals' serological responses to all known human viruses including over 443 species and 1,571 strains of human pathogenic and non-pathogenic viruses at the epitope level. The facility has successfully supported the research projects on immune response of HIV-infected patients, neuroinflammatory disease, lung cancer, prostate cancer, and liver cancer.